Tissue regulation of T cell function - Imaging Core

PROJECT SUMMARY/ABSTRACT – IMAGING CORE
The host response to pathogen infections is not confined to a single tissue, thus maintenance of homeostatic
immune surveillance and the development of protective immune responses require that cells in the immune
system constantly patrol the entire body, efficiently crossing multiple tissue barriers. Furthermore, in their target
sites, immune cells often have to find customized tissue-specific solutions to effectively identify and eradicate
pathogens. As such, the direct observation of leukocyte adhesion, migration and communication in lymphoid
and non-lymphoid tissues with microscopy is one of the most important experimental approaches. The Imaging
Core (Core B) has been established based on a stated need of PPG investigators and is designed to draw on
the considerable experience of its key personnel to provide expertise and specialized equipment in the design
and execution of in vivo imaging studies of effector T cell functions in infected tissues. The main missions of
the Imaging Core are as follows: 1. To provide state-of-the-art imaging capabilities in conducting specific
experiments regarding leukocyte adhesion and migration as well as cell-cell interactions during local immune
responses in as many as six dimensions (i.e. 3D-space, time, color, fluorescence signals). 2. To develop a
novel hyperspectral multiphoton microscopy for multicellular in vivo imaging. 3. To provide technical assistant
for analysis of the collected image data. 4. To provide assistance in the planning of in vivo animal studies by
offering standardized infectious/inflammation models and a custom-designed environment with appropriate
biosafety conditions for the generation, housing and intravital microscopy analysis of live cell cultures,
explanted tissues, and infected mice. The Cores have already been highly effective in achieving some of these
goals by providing service that both facilitates research and fosters collaborations between investigators, and
by enabling development of novel in vivo animal models and imaging techniques.